Epigenetic Mechanisms of Positive Affective State of AUD

Project Summary
As a hallmark of alcohol use disorder (AUD), the withdrawal syndrome includes both negative symptoms like
anxiety and motivational symptoms such as craving for alcohol, which promotes relapse and alcohol seeking.
Understanding how alcohol withdrawal changes brain physiology is an important step towards developing
effective treatments to reduce alcohol abuse. The ventral tegmental area (VTA) is an important brain area that
projects to components of the extended amygdala, including the nucleus accumbens, prefrontal cortex,
amygdala and hippocampus. Changes in the physiology of VTA neurons induced by withdrawal may underlie
the alcohol-seeking during AUD. The sensitivity of neurons of the VTA to inhibition by gamma aminobutyric acid
(GABA) is decreased during alcohol withdrawal but normalized by histone deacetylase (HDAC) inhibitors,
indicating epigenetic changes induced by withdrawal in the VTA may be amenable to pharmacological
manipulation. Whole genome sequencing and molecular studies of this project identified a cluster of genes that
encode cholesterol synthesis pathway enzymes that showed decreased expression during alcohol withdrawal,
and are functionally relevant to decreased GABA sensitivity in VTA neurons during withdrawal. The proposed
project plans to further characterize the role of specific epigenetic modifications in withdrawal-induced regulation
of genes responsible for cholesterol synthesis, and the effect of these changes in withdrawal-induced GABA
hyposensitivity and drinking behaviors. By using electrophysiological, behavioral, and state of the art molecular
biological methods such as chemogenetics and CRISPR technology, we anticipate achieving the following goals:
1) to reveal novel epigenetic marks and changes in gene expression associated with chronic alcohol exposure
and withdrawal with whole genome approaches, 2) to examine whether decreased histone acetylation and
increased histone methylation reduce expression of cholesterol synthesis enzymes in the VTA during withdrawal
in a cell-type specific manner, and probe the role of cholesterol synthesis enzyme genes in withdrawal-related
drinking behavior and GABA hyposensitivity, 3) to determine whether targeted epigenetic intervention
counteracts withdrawal-induced phenotypes by using CRISPR to prevent decreases in histone acetylation on
promoters of key cholesterol synthesis enzyme genes, and 4) to translate to post-mortem human alcoholic VTA
the epigenetic dynamics and expression of genes related to GABA hyposensitivity that have been identified in
the rat VTA. Ultimately, these studies are needed to understand epigenetic adaptation of VTA neurons involved
in the positive affective state during alcohol withdrawal, and, with the other components of this Center, will
provide a great deal of information on epigenetic mechanisms involved in withdrawal-induced brain changes,
and possible pharmacological approaches toward more effective treatment of AUD.